Mitochondrial-Encoded Regulators of the Nucleus and Cellular Homeostasis

ABSTRACT
Our cells have two genomes, each compartmentalized in the nucleus and mitochondria. The bi-genomic cellular
system was established through co-evolution of the early endosymbiotic bacterial genome and the proto-nuclear
genome of our ancestral cell over a billion years. Reflecting their long and close relationship, mitochondria and the
nucleus actively communicate with each other to coordinate various cellular functions. Such mitonuclear
communication is vital to cellular fitness and aging, and increasingly appreciated to be highly sophisticated and
complex. However, whereas >1,000 nuclear-encoded proteins directly regulate the mitochondria, no mitochondrial-
encoded factors have been known to actively regulate the nucleus. We recently published the first-in-class
mitochondrial-encoded peptide (i.e. MOTS-c) that regulates the nuclear genome. Here, we present an unpublished
novel mitochondrial-encoded gene that is genetically linked to MOTS-c, which we named MOTS-b. Notably, MOTS-
b and MOTS-c interact with each other in the nucleus, determined by co-immunoprecipitation-coupled proteomics
(mass spectrometry). Like MOTS-c, the nuclear translocation of MOTS-b appears to be regulated as an adaptive
response. For instance, MOTS-b and MOTS-c both dynamically translocate to the nucleus in a temporally
coordinated manner upon monocyte differentiation. Further, MOTS-b is enriched in purified nuclear chromatin
samples and can directly bind DNA based on our in vitro evolution studies to identify specificMOTS-b-targeted
nucleotide sequences. At the functional level, MOTS-b treatment regulates cellular proliferation and metabolism,
which again is consistent with MOTS-c.
Here, we propose to characterize and validate the nuclear role of MOTS-b. The overarching hypothesis of this
proposal is that MOTS-b is a novel mitochondrial-encoded gene that translocates to the nucleus and directly
regulates adaptive gene expression in coordination with MOTS-c. First, we will characterize the molecular and
cellular mechanisms of MOTS-b using a multipronged approach including mutagenesis, co-immunoprecipitation,
proximity-labeling assisted proteomics, and DNA-binding assays. We will map the functional peptide domains of
MOTS-b pertinent to DNA binding and peptide interaction, which we hypothesize to be important for its nuclear
role. We will also determine the cellular context/event that triggers MOTS-b to translocate to the nucleus. Then,
we will determine the MOTS-b-induced transcriptome by global unbiased RNA-seq with and without stress, which
will be complemented by genome-wide mapping of MOTS-b-bound chromatin sites (ChIP-seq) that are within open
chromatin (ATAC-seq). We will then screen candidate genes that mediate the effects of MOTS-b on cellular
proliferation and metabolism.
Understanding the contributions of regulators encoded in the mitochondrial genome will provide a more
comprehensive genomic perspective with added biological significance. If successful, we predict that our study will
have broad and lasting impact on (i) basic biology of aging by identifying a novel family of mitochondrial-encoded
regulators of the nuclear genome, which provides another layer of complexity to gene regulation in our co-evolved
bi-genomic cellular system and their role in aging and age-related diseases, and (ii) translational development by
describing the mtDNA as a source of novel therapeutic/diagnostic targets.

Public health relevance
PROJECT NARRATIVE Our cells operate on a bi-genomic system, whereby independent genomes in the nucleus and mitochondria are coordinated through communication to maintain cellular fitness. However, whereas over 1,000 nuclear-encoded proteins regulate mitochondria, only one mitochondrial-encoded factor has been reported to actively regulate the nucleus. Here, we propose to leverage a novel mitochondrial-encoded gene that we identified to investigate a putative family of mitochondrial- encoded peptide regulators of the nuclear genome, which has broad fundamental implications for aging and age-dependent diseases.